TASK ORDER 12: COMMUNITY ENGAGED RESEARCH INITIATIVE

The purpose of this task order is to provide overall administrative, clinical research support, statistical, and database services related to all community engaged research support activities. This includes support areas such as evaluation, arranging and managing onsite and offsite conference activities, and database updating. The primary objective is to provide services and deliverables through performance of support services for community engaged research activities. This Task Order shall specifically provide support for the annual Women’s Health Awareness Day event, and shall also provide support for other community engaged research activities as necessary.